Vamorolone trial in Becker muscular dystrophy

Abstract
Becker dystrophy is caused by partial loss of function of the dystrophin protein in muscle tissues and some
non-muscle cells, with progressive dysfunction of skeletal and cardiac muscle. Mutations of the DMD gene
cause both Becker dystrophy and Duchenne muscular dystrophy (DMD); DMD is complete loss of dystrophin,
whereas Becker dystrophy patients retain partly functional dystrophin in muscle that reduces the severity of the
progressive disease. Therapeutic efforts for DMD have significantly advanced over the last decade, with 4
drugs now approved by FDA for DMD. Clinical research in Becker dystrophy is under-represented relative to
DMD, with no drugs approved, and few drug development efforts. This discordance in therapeutic efforts is
likely partly due to somewhat lower prevalence of Becker dystrophy vs. DMD in the USA (Becker dystrophy
0.36/10,000; DMD 1.02/10,000), and the very variable clinical phenotype of Becker dystrophy (complicating
interpretation of outcomes in clinical trials). Corticosteroids (prednisone and Emflaza) are considered standard
of care for DMD, but not Becker dystrophy, as patients and their physicians generally feel that the poor safety
profile of chronic corticosteroid use outweighs benefits in strength and mobility. Here, we seek to initiate clinical
development of vamorolone (a partial dissociative agonist of the glucocorticoid receptor, and antagonist of the
mineralocorticoid receptor) for Becker dystrophy. Vamorolone shows unique structure/activity relationships
compared to the corticosteroid class and has shown preliminary data in DMD suggestive of retention of
efficacy but loss of safety concerns of the corticosteroid class of drugs. Vamorolone may show improved
efficacy in Becker dystrophy compared to DMD, as vamorolone has been shown to inhibit dystrophin mRNA-
targeting microRNAs, and thus is anticipated to increase dystrophin levels in Becker dystrophy patient muscle.
Thus, vamorolone may have multiple mechanisms of action of efficacy in Becker dystrophy: 1. Inhibition of pro-
inflammatory NF-κB pathways; 2. Increase in dystrophin content of muscle via dystrophin-targeting microRNA
inhibition; 3. Cardiac benefit via mineralocorticoid antagonism. Aim 1 of the proposed research is to evaluate
safety, tolerability, and efficacy of 6mg/kg/day vamorolone for 24 weeks treatment of patients with Becker
dystrophy. Aim 2 is to evaluate treatment responsiveness of serum biomarkers over 24 weeks vamorolone
treatment of patients with Becker dystrophy. Aim 3 is to use open-label functional outcome data (NSAA,
TTRW), carry out sample size calculations to adequately power and design a registration trial of vamorolone in
Becker dystrophy.

Public health relevance
Resume Becker dystrophy is a progressive disorder of skeletal muscle and heart that typically leads to progressive disability. The cause of Becker dystrophy is alternations to the DMD gene that lead to biochemical defects of the dystrophin protein in muscle tissues. There are no approved therapies for Becker dystrophy in the US or elsewhere. The proposed research will carry out a clinical trial of vamorolone in Becker dystrophy, with the goal of providing preliminary data on efficacy and safety. The proposed research would enable a future registration trial of vamorolone in Becker dystrophy.